Sleep and Cardiometabolic Health in United States Hispanic/Latino Late Adolescents/Young Adults

Project Summary/Abstract
Cardiometabolic (CM) disease is accompanied by increased cardiovascular (CV) risk. Therapeutic and
lifestyle interventions can target and reduce one or more CM risk factors, and thus prevent or delay adverse CM
outcomes and reduce CV mortality. However, the decline in CV mortality has flattened over the past decade,
likely due to the growing prevalence of hypertension, obesity, diabetes, and other emerging CM risk factors
(including and especially sleep disorders). Therefore, it is critical to: 1) delineate the substantial heterogeneity in
multi-modal interconnected CM risk factors, and 2) develop new classification criteria for CM risk subgroup
discovery, enabling novel targeted multi-modal intervention to reduce CM risk in high-risk subgroups and improve
CM health. However, existing research on CM risk subgroup discovery has three critical knowledge gaps.
GAP I: Prior research has focused on the middle-aged and older adult population, with limited research on
early-onset CM risk factors in the younger population. GAP II: Unlike traditional CM risk factors, sleep deprivation
and mental stress are emerging CM risk factors. However, they are very poorly understood, particularly in U.S.
Hispanics/Latinos. GAP III: The newly available Hispanic Community Health Study (HCHS) investigates the
prevalence of CM diseases and risk factors among Hispanics/Latinos and offers unprecedented opportunity to
identify subgroups at high-risk for CM diseases among Hispanic/Latino late adolescents/young adults, but there
is a lack of structured multi-dimensional analytical approaches with direct capacity to analyze and cluster the
multi-modal interconnected CM risk factors. This rich and comprehensive dataset is under-utilized.
We propose a secondary analysis to: 1) develop a novel sparse multi-modal Structural Equation Model
(multi-SEM) to cluster multi-modal mixed-typed risk factors; 2) apply the developed algorithm to identify and
characterize high-risk vs low-risk CM disease subgroups based upon subgroup-specific profiles across multi-
modal sleep disruption, mental and acculturation stress, metabolic dysregulation, obesity, physical inactivity, and
poor nutrition among late adolescents/young adults from the HCHS dataset. Specific Aims are:
Aim 1: Develop a novel sparse multi-SEM for CM risk subgroup identification and characterization from multi-
modal mixed-typed risk factors.
Aim 2: Apply the sparse multi-SEM to the HCHS dataset to: (1) identify, characterize, and validate CM risk
subgroups from multi-modal CM risk factors; (2) summarize reproducible CM risk subgroups among the
Hispanic/Latino late adolescents/young adults.
Impact: This study will help provide evidence-based guidelines and interventions for integrated multi-modal
cost-effective and early interventions targeting subgroups with early-onset risk for adverse CM outcomes among
Hispanic/Latino late adolescents/young adults, eventually improving the transition from adolescent to adult health
care and reducing CM health disparities and health care costs in the U.S. Hispanic/Latino population.

Public health relevance
Project Narrative Cardiometabolic (CM) diseases, encompassing cardiovascular and metabolic diseases like hypertension and diabetes, are positively associated with multi-modal risk factors, but existing research on CM risk factors and their association are very limited for the under-represented Hispanic/Latino late adolescents/young adults in the U.S. This study proposes to identify high-risk vs low-risk subgroups for CM diseases from multi-modal CM risk factors including sleep disorders, mental and acculturation stress, metabolic dysregulation, obesity, physical inactivity, and poor nutrition by utilizing rich data in a large community-based epidemiological study, i.e., Hispanic Community Health Study. The findings of this study will help provide evidence-based guidelines and strategies for integrated multi-modal cost-effective and early interventions targeting subgroups with early-onset risk for adverse CM outcomes among the Hispanic/Latino late adolescents/young adults, eventually improving the transition from adolescent to adult health care and reducing CM health disparities and health care costs in the U.S. Hispanic/Latino population.